Tissue Culture Core - Core A

Core A–Tissue Culture Core will be responsible for providing investigators with cultured cells, monoclonal antibodies, recombinant proteins, and recombinant adeno-associated viruses. The Core will be directed by Dr. Joseph Goldstein, who has served as its Principal Investigator for the past 40 years. The technical work in the Core is carried out by five experienced technicians, one of whom (Lisa Beatty) has been in charge of this facility for the past 28 years. The physical facilities of the Core consists of three suites of rooms that are used solely for tissue culture. The facility is equipped with 40 incubators, 14 inverted microscopes, 1 stereo microscope, 16 sterile work areas (hoods), 2 roller bottle apparatuses, 5 refrigerated incubator shakers, 3 table-top refrigerated centrifuges, 11 refrigerators, and 7 liquid nitrogen freezers for storage of cell lines. The success of the entire Program Project Grant depends on the smooth operation of this Core. Over the past 40 years, we have developed considerable experience in maintaining quality control and in growing multiple cell lines, including over 1100 different primary human fibroblast cell strains, derived from skin biopsies from normal subjects as well as from patients with metabolic disorders. Since 1984, tens of thousands of transfection experiments have been carried out in which we have introduced into various cell lines (e.g., HEK- 293, CHO, and SV589 cells) multiple plasmid constructs containing either the protein-coding region or the promoter/enhancer region of multiple genes. From these transfections, more than 3000 stable and permanent cell lines have been clonally established and frozen away in multiple aliquots. In addition to maintenance of stock cell lines and preparation of cultured cells for experiments, the Core is involved in the following activities: 1) Generation and maintenance of mouse and rabbit hybridoma cell lines and production of monoclonal antibodies from culture medium; 2) Purification by Protein A-Sepharose chromatography of more than 25 different polyclonal rabbit antibodies directed against multiple proteins; 3) Growth of large volumes of suspension-culture cells that allow efficient transfection of cDNAs and production of their encoded proteins; 4) Isolating, maintaining, and freezing away cloned cell lines that have been transfected with mutated versions of various cDNA and promoter/enhancer constructs; 5) Maintenance of insect cells in suspension culture for production of recombinant proteins by infecting these cells with recombinant baculoviruses encoding cloned cDNAs; 6) Production of recombinant adeno-associated viruses and lentiviruses, which are used for evaluating the function of genes in cultured cells and in the liver after in vivo injection; 7) Sending aliquots of monoclonal and polyclonal antibodies and cell lines to hundreds of investigators who request them. C/PPG 2015 ? Core A ? 30-line Summary

Public health relevance
The successful execution and completion of all four Research Projects in this Program Project Grant (PPG) are crucially dependent on the efficient and smooth operation of Core A–Tissue Culture Core. This Core provides all the cultured cells, monoclonal antibodies, recombinant proteins, and recombinant adeno- associated viruses and lentiviruses for all experiments done by Investigators in the PPG. This Core is directed by Joseph L. Goldstein, M.D., who has been its Principal Investigator for the past 40 years, and its day-to-day operation is carried out by five experienced technicians, including the head technician (Lisa Beatty) who has worked in the Core for the past 28 years. C/PPG 2015 - Core A - 3-Sentence Narrative